Artificial Intelligence Assisted Optical Coherence Tomography for Differential Diagnosis and Management of Irregular Corneas

PROJECT SUMMARY
To see well, the cornea must maintain near-perfect clarity and shape. Several disease processes can distort
the corneal shape and degrade vision. These include ectasia/keratoconus (stromal thinning and bulging),
edema (corneal swelling due to endothelium dysfunction), primary epithelial deformation (contact lens-related
warpage, dry eye, epithelial basement membrane dystrophy), stromal opacities (scar, ulcer, stromal
dystrophy), and other stromal shape changes (corneal surgery). Some of these conditions can appear similar
on standard corneal topography yet require very different treatments. Anterior eye optical coherence
tomography (OCT) has the potential to be an all-in-one device that can measure corneal shape, thickness, and
reflectance deviation with high resolution. Therefore, this project aims to use OCT, a 3-dimensional imaging
technology with micrometer-level resolution, to differentiate between different types of corneal shape
irregularities. The unique ability of OCT to map epithelial thickness, anterior & posterior topography, and the
reflectance of various corneal layers will be used to develop new metrics for staging and monitoring the
progression of ectasia (keratoconus) and endothelial dysfunction (Fuchs’ endothelial corneal dystrophy). Our
overall goal is to improve the early detection, differential diagnosis, staging, monitoring, and treatment of
irregular corneas by advancing the interpretation of anterior eye OCT with mathematical analyses and artificial
intelligence (AI). The specific aims are:
(1) Develop an OCT-based AI system to classify corneal irregularities. AI is needed to help the clinician
detect pathologic features and synthesize the rich quantitative information that OCT provides on
corneal shape, thickness, and reflectance patterns. AI-aided diagnostic classification can help the
clinician make management decisions.
(2) Develop OCT metrics to assess disease progression and treatment efficacy. Chronic progressive
corneal diseases such as ectasia and endothelial dysfunction require precise monitoring of
progression to determine whether and when treatment is needed. An assessment of treatment efficacy
is needed for further management decisions.
(3) Develop an OCT algorithm to predict corneal power change after endothelial keratoplasty. This is
needed for the proper selection of intraocular lens power in combined endothelial keratoplasty and
cataract surgery to treat both Fuchs’ endothelial corneal dystrophy and cataract, which often co-exist in
older patients.

Public health relevance
PROJECT NARRATIVE Treatment decisions for corneal diseases are based on their etiology, severity, and rate of progression. This project aims to develop novel ways to analyze optical coherence tomography (OCT), an imaging technology with micrometer precision, to detect, differentiate, stage, and monitor corneal shape irregularities so that proper treatment can be delivered on a timely basis. Artificial intelligence systems and other algorithms will be developed to help interpret the rich information provided by 3-dimensional OCT on the shape, thickness, and reflectance patterns of the cornea.